Deciphering the selective vulnerability of basal forebrain cholinergic neurons to tauopathy

Project Summary/Abstract
Selective neuronal vulnerability is a key feature of Alzheimer’s disease (AD), which also presents with
other pathological features such as accumulation of intracellular neurofibrillary tangles and extracellular amyloid-
β deposits. It has been known for decades that the basal forebrain cholinergic neurons (BFCNs) are severely
affected in AD and highly vulnerable to early tau accumulation. The molecular mechanisms underlying
pathophysiologic changes in BFCNs remain largely understudied. An overarching goal of this proposal is to
reveal the interplay between tau pathology and cholinergic dysfunction, two key pathological features during the
progression of AD. We will test the hypothesis that pathological tau causes BFCN dysfunction, which leads to
altered cholinergic modulation of cortical function. By leveraging human induced pluripotent stem cell (iPSC)-
derived BFCNs and a novel mouse model with restricted tau expression in BFCNs, we will assess the molecular
and functional impacts of pathological tau accumulation in BFCNs at the neuronal, network, and animal levels.
Knowledge obtained through the proposed study should have broad implications for clarifying tau pathogenesis
in cholinergic dysfunction and degeneration, and inform potential therapeutics to improve the resilience of BFCNs
to treat AD and related tauopathies. Research Projects: In this proposal, we will first investigate the biochemical
underpinnings and functional alterations of BFCNs with pathological tau accumulation using an iPSC-derived
cell model in Aim 1. Subsequently, Aim 2 will systemically examine tau spreading from the nucleus basalis
BFCNs to their projected cortical areas, which may be modulated by age, tau species and neuronal activity,
using a mouse model with restricted BFCN tau expression. Lastly, Aim 3 will assess the cholinergic modulation
of cortical function, as well as behavioral outcomes in the mouse model with tau accumulation in nucleus basalis
BFCNs. These experiments will help to dissect the molecular pathways that are altered in nucleus basalis BFCNs
with tau pathology, and elucidate the functional consequences of tau accumulation in these BFCNs. Candidate
Development and Environment: The training plan outlines the approaches that the candidate will employ to
engage the rich resources available in her laboratory and the neuroscience community at NYU Langone Medical
Center. During the K award, the candidate will expand her expertise in cellular and molecular neuroscience, in
vitro disease modeling, and functional studies. Additionally, she will gain expertise in proteomics, animal
behavioral assessment, and in vivo brain circuitry studies. The candidate has assembled a diverse team of
mentors, advisors and collaborators for the proposed project. This will ensure successful completion of the
studies by leveraging her unparalleled environment and resources. Overall, this project will ultimately enhance
the candidate’s career goal of building an independent research program to study the pathogenesis of AD and
develop effective therapeutics to treat this disease.

Public health relevance
Project Narrative The proposed research seeks to clarify the selective vulnerability of basal forebrain cholinergic neurons to tau pathology, two key pathological features of Alzheimer’s disease. Using novel human induced pluripotent stem cell-derived basal forebrain cholinergic neuron and mouse models, we seek to elucidate the neuronal and network deficits resulting from pathological tau accumulation in basal forebrain cholinergic neurons. Knowledge obtained from these studies will provide critical insights into the selective regional and cellular vulnerability in Alzheimer’s disease, which is important in developing effective treatments for this disease.